Spatiotemporal control of tendon healing through modular, injectable hydrogel composites

PROJECT SUMMARY
Biomaterials-based approaches have potential for treating tendon injury, the chronic sequelae of which include
pain, diminished function, and heightened risk of reinjury due to aberrant scar formation. Unfortunately, the
undefined origin and function of numerous cellular players involved in the tendon injury response have made it
difficult to identify biological mechanisms of these poor outcomes. As a result, therapeutic targets for
biomaterials-mediated tendon repair approaches have not been established. Recently, it has been shown that
neonatal mice fully regenerate completely transected tendons. Key differences in their injury response compared
to that of adults suggest that recruitment of progenitor cells and their subsequent tenogenic differentiation can
lead to regenerative healing. Thus, the long-term goal of the proposed work is to develop a biomaterial therapy
capable of coordinating multiple, distinct phases of tendon healing. Toward this end, we aim to design a synthetic,
hydrogel-based composite scaffold that integrates physical (mechanical and topographical) and soluble cues to
1) recruit specific progenitor cell populations to the injury site and 2) direct tenogenic progenitor cell differentiation
and de novo matrix synthesis of the appropriate composition and organization following tendon injury. Our central
hypothesis is that spatiotemporal presentation of combinatorial microenvironmental cues can control the
abundance and identity of reparative cells entering the injury site and promote their differentiation and matrix
remodeling activity, both of which will improve the adult tendon healing response. Our preliminary data
establishes a material that is permissive to tendon progenitor cell (TPC) migration and tenogenic differentiation;
moreover, we have established a tunable soluble factor release system enabling gradual release of chemotactic
cues and cell-triggered release of differentiation factors. We have already found that physical and microgel-
delivered soluble cues synergistically enhance TPC recruitment into these composite hydrogels. Therefore, in
Aim 1, we will optimize microenvironmental cues for driving robust tenogenic differentiation in vitro. In Aim 2, this
dextran vinyl sulfone-based material system will be tested in a murine Achilles tendon injury model to study the
effects of these cues on recruitment of TPCs to the wound site, subsequent tenogenesis, and matrix
deposition/organization. The extent of tenogenic differentiation will be quantified through the expression of a
panel of tenogenic factors, deposition of organized de novo matrix supporting tenogenesis, and functional
analysis of regenerated tendons. This work will establish a novel, injectable, modular hydrogel scaffold capable
of driving a robust tendon healing response in adult mice. Moreover, this work will provide a deeper
understanding of the microenvironmental cues regulating tenogenesis, information critical to the advancement
of biomaterial therapeutics geared toward connective tissue regeneration.

Public health relevance
PROJECT NARRATIVE Natural adult tendon healing involves aberrant scar formation leading to diminished function and frequent reinjury. Biomaterials delivering physical and soluble microenvironmental cues that orchestrate distinct phases of regenerative wound repair are a promising future treatment for tendon injury. The proposed work will integrate tunable, synthetic biomaterials and novel soluble factor delivery systems to create a modular, injectable hydrogel with spatiotemporal control over two key phases of tendon healing: 1) progenitor cell recruitment to the injury site and 2) tenogenic differentiation contributing to functional tissue regeneration.